Defining viral and immune mechanisms of Dengue virus serotype 2 immune evasion

Project summary Dengue virus (DENV) is one of the most significant arthropod-borne viruses currently leading to >390 million human infections worldwide. DENV can cause severe disease and death in children and the elderly in endemic regions such as Asia and Latin America. DENV is genetically and serotypically divided into four serotypes (1-4) and each serotype can be further subdivided into distinct genotypes. Alarmingly, in the next 50-80 years, DENV infections are projected to spread to new areas of the world, including the United States, putting millions of additional individuals at risk for DENV disease. Moreover, the only licensed DENV vaccine does not perform equally well against the existing four DENV serotypes. The vaccine efficacy against DENV serotype 2 (DENV2) is remarkably low (39% efficacy), underlining the need to improve DENV vaccine design and strategies. While it is known that DENV genetic diversity exists among the four serotypes, the role of DENV intraserotypic diversity within the distinct genotypes in modulating neutralization resistance to vaccine-elicited antibodies is not well understood. Therefore, this project aims to define the role of naturally occurring DENV2 genetic variation on neutralizing antibody evasion. This project also aims to define IgG Fc characteristics, such as IgG subclass and Fcγ receptor binding, of vaccine-elicited binding and neutralizing antibodies in NIH vaccinees. To complete this project, I have generated a DENV2 genotype variant virus panel using reverse genetics. Importantly, this genotype panel contains contemporary isolates from distinct regions in the world including: Asian I, Asian II, Asian-American, Cosmopolitan, Sylvatic African, and Sylvatic Asian isolates. I discovered that these DENV2 genotypic variants exhibit considerable amino acid residue variability within the prM and in E domain I (EDI), II (EDII), and III (EDIII), which are key targets for neutralizing antibodies. Interestingly, my preliminary data demonstrates that the genotypic genetic diversity observed in DENV2 modulates differential neutralization sensitivity to both neutralizing monoclonal antibodies and polyclonal antibodies from DENV2- infected individuals. I will therefore evaluate the role of DENV2 genetic diversity in modulating neutralization resistance to vaccine-elicited neutralizing antibodies from NIH monovalent DENV human vaccinees and tetravalent DENV human vaccinees. Moreover, I will define the Fc region characteristics, such as IgG subclass and binding to Fcγ receptors, of these vaccine-elicited antibody responses that mediate protection in a human challenge model of DENV infection. A better understanding of the mechanism(s) by which DENV evades neutralizing antibodies will be critical to improve the existing DENV2 vaccine that performs poorly. These project findings will provide crucial information on the strategies that DENV2 employs to subvert host-elicited neutralizing antibodies, which will be important to rationally design DENV vaccines aimed at improving vaccine efficacy.

Public health relevance
Project Narrative A safe and effective Dengue virus (DENV) vaccine that can provide uniform protection against the existing four serotypes is urgently needed. Therefore, this proposal seeks to understand the underlying mechanisms of DENV2 virologic determinants – such as prM-mediated virion maturation, E protein genetic variation, and the Fc region characteristics of vaccine-elicited antibodies – that are predictive of neutralizing antibody evasion and of antibody-mediated protection of the DENV2 NIH vaccine. Defining the determinants of efficacious DENV2 vaccines will be crucial to improve existing DENV vaccine designs and formulations.